Antimicrobial Resistance Monitoring in Bacteria of Veterinary Significance

Project Summary/Abstract
The NYS Veterinary Diagnostic Center/Cornell Animal Health Diagnostic Center at Cornell University (AHDC)
is a full-service multidisciplinary veterinary diagnostic laboratory and the only of its kind in the northeastern
United States. The AHDC received over 300,000 client accessions in 2023. The Bacteriology section has
MALDI-TOF analyzers, Sensititer systems, veraTREK® blood culture instruments, a BSL3 upgradable
workspace, and 16S DNA sequencing capabilities, making it a full-service bacteriology laboratory. Additionally,
the AHDC has the capacity to perform whole genome sequencing. The Bacteriology laboratory of the AHDC
performed over 100,000 tests in 2023 on clinical samples, tissues, serum, bacterial isolates, environmental,
food, and feed samples, including over 5,000 antimicrobial sensitivity panels. The AHDC has partnered with
the FDA and played an active role in pet food and animal feed contamination investigations many times over
the past two decades. We hope to continue our participation with the FDA Vet-LIRN program and other
network laboratories to:
1. Continue to participate in VPO designated sample analyses and surveillance activities to promote
animal health and welfare and add to the Vet-LIRN Network’s surge capacity to assist in emergency
and large-scale outbreak testing.
2. Provide analytical data to support regulatory actions by developing and using standardized methods,
equipment platforms, and reporting methods. Continuing to participate in proficiency testing provided by
the VPO, continue investigating consumer reported cases as requested by the VPO, and continuing to
improve and implement standardized quality management systems as designated by the VPO.
3. Continue to participate in small-scale antibiotic susceptibility testing studies to address emerging
antimicrobial resistance issues, acting as a source laboratory for the FDA Vet-LIRN AMR monitoring
project to collect and submit bacterial isolates and associated antimicrobial susceptibility data.

Public health relevance
Project Narrative Emergence of antibiotic resistance continues to be a threat to both human and animal health around the world, and this burden can be reduced with the prudent use of antibiotics through culture and susceptibility testing. The AHDC Bacteriology laboratory is engaged to continue its cooperative agreement with the FDA Vet-LIRN to promote the areas of food and feed surveillance, antibiotic susceptibility testing, quality management, animal health, food safety, and food security. As a continued participant in the Vet-LIRN network of veterinary diagnostic laboratories, the AHDC Bacteriology laboratory can provide surge capacity for large-scale testing in the event of an emergency.